Community Outreach and Engagement

CCSG COMPONENT 005 – COMMUNITY OUTREACH AND ENGAGEMENT
PROJECT SUMMARY/ABSTRACT
Vanderbilt-Ingram Cancer Center (VICC) is located in a region with some of the highest cancer incidence and
mortality rates in the US. As the only NCI-designated Comprehensive Cancer Center serving both adult and
pediatric populations in Tennessee (TN), VICC encompasses a geographically wide and demographically
diverse catchment area of 123 counties across TN, western Kentucky (KY), and northern Alabama (AL) from
which 90% of VICC cancer patients currently are drawn. Seventy of the 123 counties (57%) are classified as
rural, in which 25% of the catchment area population lives. VICC Community Outreach and Engagement (COE),
under the leadership of Associate Director Pamela Hull, PhD (CO), integrates with VICC Research Programs
and administrative initiatives to reduce the cancer burden and disparities within the catchment area and beyond.
In a bi-directional manner, leveraging relationships with patients and community stakeholders, COE obtains input
from the community on priorities for research, cancer control and care and works with VICC research programs
and community partners to bring those prioritized initiatives out to the community. The specific aims of COE are
to: 1) Assess and prioritize cancer-related needs and opportunities in the catchment area; 2) Inform and facilitate
programmatic research that is responsive to identified cancer-related needs and community-driven priorities;
and 3) Promote the implementation and dissemination of evidence-based cancer prevention, control and care.
Community-driven priorities identified through COE include cancer prevention initiatives, improved access to
care through technology, holistic treatment and support, implementation of evidence-based practice and policy,
advancing discoveries, and research advocacy. VICC conducts basic, clinical and population science research
that addresses catchment area needs and aligns with these community-driven priorities. COE staff collaborate
with partners to meet evolving community-identified needs through a variety of collaborative community outreach
activities. Working together with partners and stakeholders, VICC community-informed research and cancer
control activities synergistically contribute to empowering healthy and cancer literate communities in our
catchment area and beyond. The impact of these efforts is already evident in improved practices at Vanderbilt
University Medical Center (VUMC) and affiliated sites, including newly available tobacco screening/counseling,
enhanced patient navigation, expanded reach of lung cancer screening and improved adherence to breast,
colorectal and cervical cancer screening guidelines, HPV vaccination and inherited cancer screening. Moving
forward, focus will be placed on metrics of increased accruals to research studies; improvements in cancer-
related knowledge, attitudes and behavior; and expanded implementation of evidence-based guidelines and
health policies. Together with community partners, VICC positively impacts the catchment area by enabling a
systems approach to cancer, advancing fundamental research and translating discoveries from the bench to the
clinic, community and population in the catchment area, nationally, and globally.

Public health relevance
CCSG COMPONENT 005 – COMMUNITY OUTREACH AND ENGAGEMENT PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Community Outreach and Engagement.